Transitional Alveolar Epithelial Cells in Normal Lung Development

Minoo, Parviz
ABSTRACT: In the face of injury, the adult lung mobilizes AT2 facultative stem cells to
repair and reestablish homeostasis and respiratory function. What about immature lungs
undergoing alveologenesis in prematurely born infants?
To our knowledge, there is virtually no information regarding the existence or potential
regenerative capacity in immature, AT2 cells in lungs undergoing alveologenesis. This is
important information with significant bearing on pathogenesis of BPD which results from
injuries in immature lungs during alveologenesis. The scientific premise of this project is
grounded in our surprising findings of defined intermediate/transitional alveolar epithelial
cells (AEC) in the process of AT2→AT1 differentiation in murine neonatal lungs undergoing
alveologenesis. We show for the first time that these “normal” intermediate/transitional cells
share several transcriptional features with recently reported transitional/intermediate AECs
that accumulate in human IPF and murine bleomycin injury models and thought to be cells
“caught” in the AT2→AT1 differentiation process as part of the regenerative response to injury.
This suggests that the biological mechanisms of AT2→AT1 process during normal alveologenesis
may have molecular and functional overlapping similarities to those of AT2→AT1 differentiation
during regenerative repair in response to lung injury.
The biology & functional significance of these cells in the adult or the neonate
remain largely unknown.
In preliminary data we demonstrate that the neonatal intermediate/transitional AECs in
immature lungs during alveologenesis reside within alveolar niches in close proximity to
Hedgehog-responsive, Pdgfra(+), mesenchymal cells we first identified as Secondary Crest
Myofibroblasts or SCMF. Genetic loss of function studies show that SCMF control the
ontogeny of intermediate/transitional AECs and in particular self-renewal of a unique
proliferative AEC subpopulation during alveologenesis. SCMF are in turn maintained by
TGF-beta signaling. Therefore, SCMF~AEC axis constitutes an alveolar intra-niche
communication network.
In this application, combining our results in normal neonatal lung, with findings from adult
injury and disease models, we will use a multiplex technical approach that combines single
cell RNA sequencing, snRNAse+sc/ATACseq Multi-Omic, in vivo lineage tracing, hyperoxia
injury model and 3D organoid cultures to conduct “deep-dive” studies into the biology of
neonatal intermediate transitional AECs and their regulation in neonatal and adult mouse
lungs. We project that the deliverables from these studies will impact not only our
understanding of pathogenesis of neonatal chronic lung disease BPD, but also may provide
significant insight into the biology of the recently found “aberrant” transitional epithelial cells
in adult pulmonary diseases such as IPF.

Public health relevance
Narrative : This project will use state-of-the-art molecular and cellular approaches to elucidate the mechanisms of the lung regenerative stem cell system during the neonatal period. The findings from this project will be useful for development of therapies for lung disease.